Eating disorders in Veterans: Risk, resilience, and service use

Background
Eating disorders (EDs) likely affect a significant proportion of female and male Veterans; however, they remain
understudied and under-treated in VA. Individuals with EDs are likely to be high users of medical care, which is
at least partly due to the physical complications of EDs. Nonetheless, EDs often go undetected in general
medical settings, unless providers screen for them. Currently, the VA does not routinely screen for EDs; thus,
enhancing VA's capacity nationally to provide comprehensive care for Veterans with EDs is a priority area of
focus. This proposal will address four major gaps: the lack of prevalence estimates of EDs in nationally
representative samples of Veterans, the lack of knowledge of healthcare needs and preferences of Veterans
with EDs, the paucity of findings regarding military/Veteran-specific risk factors for EDs, the lack of a validated
screening measure for EDs in Veterans, and the lack of knowledge regarding Veteran preferences for ED
screening. These gaps are barriers to screening for and treating Veterans with EDs in VA healthcare.
Objectives
The specific aims are to establish a nationally representative cohort of male and female Veterans in order to: 1)
a) examine the prevalence of male and female Veterans reporting full and subthreshold EDs and b) to examine
the potential prevalence of EDs among vulnerable subgroups of Veterans; 2) to identify service use and needs
among male and female Veterans with full and subthreshold EDs; 3) to estimate models of risk and protective
factors for EDs, including military sexual trauma, combat trauma, and unit and family deployment support; and
4) to validate an existing screening measure of EDs in a Veteran sample and assess screening preferences.
Methods
In order to achieve these aims, we will recruit a nationally representative sample of 1500 male and female
Veterans. We will request that the VA/DoD Identity Repository (VADIR), a VA office with access to Department
of Defense records, assist in randomly selecting 3750 individuals from the national Veteran population. We will
stratify the sample based on race/ethnicity and oversample women to achieve a 1:1 ratio. We will mail a
comprehensive survey to potential participants using a multi-pronged, six-stage mailing strategy.
Participants will complete survey measures of ED symptoms, risk and protective factors, and VA and non-VA
healthcare service and needs. Aim 1: sample weighting procedures will be used in order to calculate nationally
representative prevalence estimates of EDs among male and female Veterans. Aim 2: Poisson regression will
be used to compare healthcare service use for Veterans with EDs to Veterans without EDs. In addition, we will
use descriptive statistics to report service use among male and female Veterans with full and subthreshold
EDs and which services, if available, they would like to use. Aim 3: structural equation modeling will be used to
estimate models of risk and protective factors for EDs. Aim 4: Receiver Operating Characteristic curves will be
used to estimate sensitivity and specificity of the ED screening measure, regression models will be used to
investigate criterion validity, and descriptive statistics will be used to describe Veteran screening preferences.
Dissemination Plan
We will share our findings with our Operational Partners on monthly workgroup calls and make
recommendations based on these results. Our findings regarding the scope of EDs among Veterans and their
healthcare use and preferences will be used to inform ongoing provider trainings in EDs. We also will
disseminate findings during Women's Health Cyberseminars and via newsletters such as the Women's Health
Roundup. We will develop clinician and executive briefs in order to disseminate findings to both clinicians and
policy-makers. Thus, our results will be summarized and disseminated to VA leadership in a timely manner.
!

Public health relevance
Eating disorders (EDs) are pernicious conditions with the highest mortality rate of any psychiatric disorder. Gaps in our knowledge regarding the prevalence of EDs in male and female Veterans, what healthcare services are being used by Veterans with EDs and what services Veterans with EDs would like to use if offered in the VA, the impact of military sexual trauma and combat exposure on the development of EDs, validity of ED screening measures, and Veteran preferences for screening limit VA's ability to respond to the needs of Veterans with EDs. EDs disproportionately affect women, and female Veterans are the fastest growing segment of Veterans Health Administration (VHA), underscoring the need for examination of EDs and gender similarities/differences. Our findings will provide important information regarding the scope of the problem of EDs and inform approaches for targeted screening within VA. This proposal addresses an important gap in caring for Veterans with EDs. Findings will be highly relevant to VHA clinical leaders and policy makers. !